Cardiac Myosin Binding Protein-C in Development and Reversal of Heart Failure

Heart failure (HF) afflicted 6.5 million Americans in 2017, carries 5-year mortality of ~50%, and will likely increase
to > 8 million by 2030. The lack of significant improvement in mortality for the last 46 years, the reality of needing
to discontinue effective medications due to hypotension in heart failure with reduced ejection fraction (HFrEF),
and the paucity of effective treatment for heart failure with preserved ejection fraction (HFpEF) combine to
suggest that new treatments are needed. Cardiac myosin binding protein-C (cMyBPC) resides on the thick
filament of the heart muscle. Phosphorylation of cMyBPC at its M-domain increases cross-bridge cycling rate.
Because increasing cross-bridge cycling rate can improve both contractility and lusitropy, we hypothesize that
phosphorylation of cMyBPC provides a novel central mechanism that can prevent and treat HF due to different
causes. Using mouse models that mimic de-phosphorylated and phosphorylated cMyBPC at 3 serine (S) sites
in the M-domain, we recently discover that cMyBPC phosphorylation mitigates both aged-related development
of HFpEF and trans-aortic constriction (TAC) surgery induced HFrEF, as seen by improved survival and better
preservation of diastolic function. Thus, cMyBPC phosphorylation holds potential to treat both HFrEF and
HFpEF. However, we find evidence that 2 new S phosphorylation sites outside our study of 3 S sites add
significant functional effects. Consequently, we have made 2 new knock-in mouse models to include the new
sites for elucidating the effects of maximally phosphorylated cMyBPC(5SD) and dephosphorylated cMyBPC(5SA)
M-domain. We also find evidence that pressure stress can activate focal adhesion kinase (FAK) to phosphorylate
tyrosine (Y) residue(s) in cMyBPC. This discovery leads to a new supporting hypothesis that pressure stress
triggers FAK to phosphorylate cMyBPC to increase contractility as a compensatory response. With these
discoveries in mind, we intend to determine the efficacy of maximal M-domain phosphorylation and elucidate the
novel FAK-cMyBPC mechanism. Aim #1: Determine the efficacy and companion mechanisms of phosphorylated
cMyBPC to preserve cardiac function under HF inducing conditions of aging, pressure stress, and obesity. We
will challenge mice with 2-yr aging, TAC, or high fat diet. We will use a combination of functional and biochemistry
techniques to determine the underlying mechanisms. Ability of cMyBPC(5SD) mouse to resist deterioration and
effectiveness of using cMyBPC(5SD) gene therapy to reverse failing WT hearts will quantify the efficacy of cMyBPC
phosphorylation for prevention and treatment respectively. Aim #2: Elucidate signaling mechanism and
functional results of pressure stress induced tyrosine phosphorylation of cMyBPC. We will identify Y site(s),
confirm FAK-cMyBPC interaction, and elucidate effects of FAK phosphorylating cMyBPC on models ranging
from intact papillary muscle to new knock-in mouse. Impact: Efficacy results and mechanistic insights stemming
from this study provide evidence for translating cMyBPC phosphorylation to new HF treatment.

Public health relevance
Project Narrative Persistently high 5-year death rate of ~50% for last 46 years, rising disease prevalence from 6.5 million Americans in 2017 to projected > 8 million by 2030, and lack of effective treatment for nearly 50% of the diagnoses combine to strongly suggest that heart failure needs new treatments. This research project will define how we can manipulate a heart muscle protein called cardiac myosin binding protein-C to prevent and treat heart failure.